Dissecting Polyclonal Sera to Reveal Correlates of Productive Immune Responses to HIV

Project Summary/Abstract
Broadly neutralizing antibodies (bnAbs) that arise during chronic HIV infection highlight the remarkable
capacity of the human immune system to evolve antibodies that can recognize highly variable and glycosylated
proteins. Eliciting these types of antibodies via a prime-boost vaccine however remains a difficult challenge.
Recently, structure-based rational vaccine design strategies have reinvigorated the pursuit of an effective HIV
vaccine. This approach relies on a high-resolution understanding of the interaction between the sole
neutralizing target on the surface of HIV, envelope glycoprotein (Env), and bnAbs that can be used to engineer
immunogens designed to recapitulate bnAb responses in naïve individuals. This approach is iterative and
relies on the ability to characterize immune responses in animals to such immunogens to refine the
immunogen design. Serum neutralization assays and ELISA binding provide an estimation of the elicited
immune response but not the molecular details required for rational design. Epitope mapping via alanine
scanning, antigen specific monoclonal antibody isolation, and next generation sequencing provide further
details, but each has limitations and are very time-consuming endeavors. We have therefore developed a
novel method to dissect polyclonal immune responses to provide a complete and quantitative map of the
epitopes targeted that is rapid and can inform boosting strategies in real time. By purifying immune complexes
formed between Env trimer immunogens and serum antibodies from immunized animals, and imaging them by
electron microscopy, we directly visualize polyclonal antibody responses. These responses can be quantitated
directly or in combination with deep sequencing and mass spectroscopy. We have shown proof of concept in
rabbits immunized with BG505 SOSIP.664 native-like Env trimers, and propose to use our methodology to
study a recently completed large non-human primate (NHP) vaccination study (138 animals) that tested
various immunization strategies using the BG505 SOSIP.664 platform. Within this study there are animals that
did or did not develop potent autologous neutralizing antibody responses, as well as animals that developed
some level of neutralization breadth. Hence, we have a unique opportunity to understand the molecular
underpinnings of such immune responses, and to delineate phenotypic signatures within the polyclonal
antibody responses that can be used to guide HIV vaccine development. Further, our studies can be applied to
human serum samples for an upcoming human clinical trial using the same BG505 SOSIP.664 immunogen.
And thus, we can generate comparative data between humans and NHPs to improve the utility of pre-clinical
animal models that remain an essential component of the iterative rational HIV vaccine design process.

Public health relevance
Project Narrative Evaluating polyclonal humoral immune responses remains a challenging endeavor and neutralization or ELISA endpoints provide incomplete pictures of the complexity of antibody responses to antigens. We have developed a new methodology to directly image polyclonal immune responses using electron microscopy that dramatically improves our understanding of the antibodies generated via vaccination, thereby delineating signatures of protective immune responses against HIV and providing a new tool for rational vaccine development.